Engineering protein-specific proteases: targeting signaling proteins

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
Our objective is to develop general principles for engineering proteases that can control signaling in cells. This will be accomplished as follows: 1) Choice of signaling proteins (Human RAS isoforms and oncogenic mutants); 2) Identification of dynamic regions within the signaling proteins; 3) Identification of a target sequence within dynamic regions; 4) Engineering/evolving high specificity against the target sequence; 5) Engineering zymogen activation that is catalyzed by the target protein; 6) Testing control of signaling in human cell culture. We will complete these steps using a multi-disciplinary approach that includes protein engineering, enzymology, multidimensional NMR, X-ray crystallography, and cell-biology. The three Specific Aims are: 1) Evolve protein-specific proteases that target active RAS; 2) Engineer zymogen activation catalyzed by active RAS; 3) Test promising proteases in cell model systems. This project will develop general principles of recognition, folding, and catalysis based on detailed understanding of structure and mechanism and use this knowledge to develop tools to control signaling in a cell. The protease will sense the presence of active RAS and transduce a controlled release of the active RAS-specific protease, thereby modulating RAS signaling. The ability to cleave RAS in cell-based systems and thereby alter RAS signaling will represent a significant milestone towards establishing the utility of protein-specific proteases as exogenous signaling regulators. Although these proteases target active RAS, the underlying design principles are fundamental and will be adaptable to many target proteins.

Public health relevance
Our objective is to develop general principles for engineering proteases that can control signaling in cells. In accomplishing this objective we will develop tools for controlling signaling in a cell, and ultimately create avenues to advanced therapeutics.